Spatially transparent binaural beamforming for noise reduction in cochlear implant processors

Abstract
While cochlear implants (CIs) have provided remarkable benefits to patients with severe-to-profound
hearing loss, CI users still often struggle to perceive speech in noisy environments. A number of
improvements have been developed to help CI users in such environments, including a) the use of
directional microphones and related beamforming technologies to improve the signal-to-noise ratio,
and b) the addition of a second cochlear implant on the contralateral ear (i.e., bilateral CIs), which not
only allows the user to sense the directions of sounds (localization), but also improves speech
perception in the presence of interfering noise from other directions. Most beamforming technologies
and directional microphones currently improve the signal-to-noise ratio for the target sound, but at the
cost of degrading some of the spatial cues that, if preserved, could lead to further intelligibility
improvements. Other technologies require complex mathematical transformations that increase
computational complexity or introduce significant delays.
This project proposes an innovative and practical binaural beamforming algorithm suitable for
implementation on today’s CI processors, and potentially on hearing aid platforms in the future. The
goal of the algorithm is to provide highly directional spatial filtering in real-world noisy environments,
while still retaining the advantages of binaural cues. Our approach will achieve this with efficient, real-
time processing, free of the delays inherent with many existing approaches.
The project will demonstrate feasibility of the proposed algorithm. First, a proof-of-concept
beamformer based on our recently patented Virtual Reality (VR) audio processing algorithms will be
improved and enhanced, with iterative evaluation and feedback from bilateral CI users. Second, the
feasibility of implementing the resulting software in current CI processors will be ascertained. Third,
an assessment of improvements in speech perception with background noise and sound source
localization will confirm the ability of the algorithm to provide the foundation of a practical commercial
product.

Public health relevance
Project Narrative The overarching goal of this Phase I SBIR project is to provide improved hearing experiences for users of cochlear implant (CI) devices, who despite recent technological advances, continue to struggle in noisy environments. The project aims will be achieved through an innovative algorithm that reduces noise while retaining the cues needed to determine where sounds originate from that are important for optimal intelligibility. The resulting product is expected to provide improved speech perception and quality of life for CI users.